Development of a human salivary gland-on-a-chip composed of both parenchyma and stroma to model dry mouth caused by radiotherapy

ABSTRACT
Hypofunction of salivary gland, also called dry mouth syndrome, is a common pathological condition in Sjögren's
syndrome patients and patients treated with radiotherapy for head and neck cancer. Dry mouth syndrome
significantly impairs the quality of life of affected patients. Current treatments can only temporarily relieve the
symptoms. Some novel treatments showed promising effects in animal models, but the clinical potentials of these
new therapies are difficult to evaluate due to significant differences in salivary gland structures and biology
between commonly used animal models and human, and the lack of faithful human tissue culture models. The
goal of this proposal is to establish human salivary gland organs-on-a-chip (OoC) models of normal and radiated
salivary glands that allow mechanism studies and drug screening for dry mouth syndrome caused by
radiotherapy. Currently available salivary gland OoC models are limited, focusing only on epithelial cell
components. Recent studies, including those in my lab, have shown that both salivary gland endothelial cells
and macrophages are the most radiation-sensitive cells and essential regulators of salivary gland homeostasis
and regeneration. Therefore, we will: 1) develop a normal salivary gland OoC model composed of epithelial cells,
endothelial cells, and macrophages, and validate its secretory functions; 2) develop the disease salivary gland
model based on the normal OOC model that mimick irradiation damage. These models are expected to
significantly improve drug development efforts towards restoration of salivary gland functions in head and neck
cancer patients treated with radiotherapy. The normal SG OoC will also serve as a platform for studying salivary
gland toxicity of drugs for other diseases and dry mouth caused by Sjögren's syndrome in future.

Public health relevance
PROJECT NARRATIVE Irreversible loss of saliva production or dry mouth syndrome is common in head and neck cancer survivors treated with radiotherapy and in Sjögren's syndrome patients, which decreases the quality of life of these patients remarkably and cannot be treated effectively, partially due to the lack of faithful in vitro tissue culture models. The goal of this proposal is to establish human salivary gland organs-on-a-chip (OoC) systems of normal and radiated salivary glands that allow mechanism studies and drug screening for dry mouth syndrome caused by radiotherapy. The studies have the potential to improving restoration of salivary gland function in head and neck cancer patients treated with radiotherapy, and will provide a platform for studies on salivary gland toxicity of drugs for other diseases and on dry mouth caused by Sjögren's syndrome.